Synthesis, Biosynthesis, and Structure of Antitumor Agents

DESCRIPTION (provided by applicant): Natural products continue to provide stimulation for the development of creative, interesting, or valuable new chemistry. In this application we propose studies that stem from consideration of the structures or properties of selected natural products that have anticancer properties. In Aim I new methods for the determination of the structure of natural compounds will be developed. The work will primarily address stereochemical issues-specifically, the relative configuration of unknown stereocenters. A major goal will be to develop computational methods that can routinely and reliably be used to deduce stereostructures by guiding proper interpretation of NMR data. In Aim II a new methodology, which has the potential to be broadly applicable in natural product synthesis, will be developed. Namely, relay cross (olefin) metathesis (RelayCM) will be developed. This will allow for efficient (i.e., non-statistical) cross coupling of two different alkenes, even when the two are used in an equimolar ratio. Plans for application of this strategy to accomplish a key convergent cross coupling are presented in the context of a proposed total synthesis of lyngbyaloside B (II). A polyol-acylketene macrolactonization reaction is also showcased in this synthesis. In Aim III the studies related to the biosynthesis of five target compounds will be studied. These are ottelione a (IIIa), salinosporamide A (IIIb), the putative polyenyne biosynthetic precursor to the 9-membered enediyne family (IIIc), uncialamycin (IIId), and okiloactomycin (IIIe). These include compounds with considerable biological relevance to human cancers, including one (IIIb) that is currently in two Phase I clinical trials. Mechanistic considerations, in the light of unprecedented structural features within this group of natural compounds, have led us to propose non-conventional core strategies for the synthesis of each. More specifically, the role of (chemical) spontaneity in biosynthesis drives much of that thinking. In brief, we hypothesize that many natural products undergo their final assembly by non-enzymatic, 'purely chemical' reaction cascades that occur spontaneously under the ambient conditions of the producing organism. Where true, capitalizing on this natural spontaneous event will lead to substantially more efficient chemical synthesis than would otherwise be the case. The driving hypotheses to be tested are: An ambient temperature Cope rearrangement is the key step in the biosynthesis of IIIa. The 2-lactone IIIb is biosynthesized by a spontaneous intramolecular ketene cycloaddition. The polyenyne IIIc is formed by a remarkable and spontaneous cationic cyclization of a highly unsaturated allenyldiynol. The enediyne IIId is formed by spontaneous ring opening of an o-aminoaryloxirane and cyclization of the resultant quinone methide imine. Unique reactivity pairing induces an unusual Diels- Alder reaction leading to IIIe. PUBLIC HEALTH RELEVANCE: Chemical compounds produced by organisms (i.e., natural products) are an invaluable resource. The origin of nearly half of all FDA-approved and U.S.-marketed pharmaceuticals can be traced to a natural product lead. This is also the case for chemotherapeutic agents used to treat human cancers.* Thus, the development of improved methods and strategies i) for the chemical synthesis of natural products, ii) for increasing our understanding of the pathways by which natural products are produced in nature, and iii) for the determination of the structures of new natural products-the titled objectives of this project-is essential if we are to capture the full value of the contents of nature's chemical treasure chest. * Among the currently approved drugs used in cancer chemotherapy, each of the following either is a natural product itself or is directly derived from one: actinomycin, bleomycin, doxorubicin/daunorubicin/darubici/valrubicin (from daunomycin), etoposide/teniposide (from podophyllotoxin), irinotecan/topotecan (from camptothecin), mitomycin, mylotarg (from calicheamicin), streptozotocin, taxol (and docetaxel), vincristine, and vinblastine. Many more are in various stages of clinical trial. Newman and Cragg report (J. Nat. Prod. 2007, 70, 461- 477) that over 75% of new chemical entity anticancer drugs submitted to the FDA between 1981-2006 were either natural products per se or were based thereon, or mimicked natural products in one form or another.

Public health relevance
Project Narrative Chemical compounds produced by organisms (i.e., natural products) are an invaluable resource. The origin of nearly half of all FDA-approved and U.S.-marketed pharmaceuticals can be traced to a natural product lead. This is also the case for chemotherapeutic agents used to treat human cancers.* Thus, the development of improved methods and strategies i) for the chemical synthesis of natural products, ii) for increasing our understanding of the pathways by which natural products are produced in nature, and iii) for the determination of the structures of new natural products-the titled objectives of this project-is essential if we are to capture the full value of the contents of nature's chemical treasurechest. * Among the currently approved drugs used in cancer chemotherapy, each of the following either is a natural product itself or is directly derived from one: actinomycin, bleomycin, doxorubicin/daunorubicin/darubici/valrubicin (from daunomycin), etoposide/teniposide (from podophyllotoxin), irinotecan/topotecan (from camptothecin), mitomycin, mylotarg (from calicheamicin), streptozotocin, taxol (and docetaxel), vincristine, and vinblastine. Many more are in various stages of clinical trial. Newman and Cragg report (J. Nat. Prod. 2007, 70, 461- 477) that over 75% of new chemical entity anticancer drugs submitted to the FDA between 1981-2006 "were either natural products per se or were based thereon, or mimicked natural products in one form or another."